Deciphering Translational Control in Stem Cells

Project Summary
Translational control is critical for a variety of cellular processes such as homeostasis and differentiation.
Dysregulation of translation has been implicated in many human diseases, including cancer. Stem cells are
characterized by low global protein synthesis rates, despite high levels of ribosome biogenesis, suggesting that
stem cells actively repress translation. Indeed, precise translational control has been shown to be essential for
maintaining pluripotency, as perturbations that increased translation rates induced differentiation in various types
of stem cells. Although there are several examples of how translation is regulated, the molecular mechanisms
that modulate translation, particularly in stem cells, are largely unknown. To achieve a comprehensive
understanding of translational control, I propose to systematically investigate the regulatory pathways that
mediate translation in stem cells and across cell types. I will begin by developing a genome-scale genetic
screening platform that combines CRISPR screening with polysome profiling to identify genetic perturbations
that alter translation. Compared to previous approaches that relied on reporter protein expression, the proposed
screening approach measures presence of ribosomes on mRNA, which more directly and accurately quantifies
translation rates. This screening approach is also more versatile and can be adapted for studying other modes
of translation by exchanging the reporter gene in the vector. I will then apply this screening approach to
systematically discover genes that regulate global translation levels in stem cells and fibroblasts and investigate
associated mechanisms. Finally, I will focus on genes that are selectively translated using ribosome profiling and
characterize the pathways that mediate selective mRNA translation. Together, my proposed work establishes
a framework for systematic exploration of translational control networks and, in concert with its application
in other contexts, will contribute to a comprehensive understanding of the processes controlling translation that
are relevant in development and disease.

Public health relevance
Project Narrative Translational control is critical for a variety of cellular processes and its dysregulation has been shown to disrupt development and cause many human diseases. Yet the molecular mechanisms that modulate translation, particularly in stem cells, are largely unknown. To achieve a comprehensive understanding of translational control networks, I propose to 1) develop a screening approach for studying translation that combines CRISPR with polysome profiling; 2) apply this approach to discover pathways that regulate global translation levels in stem cells; and 3) investigate selective mRNA translation using ribosome profiling.